Trusted School Messengers Promoting Non-Mandated Vaccination

This application addresses the CDC SIP-24-013 ‘Understanding the potential of schools in promoting non-
mandated childhood vaccinations.’ Influenza results in thousands of deaths and millions of illnesses in the US
each year. Children under age 4, those with high-risk conditions, and individuals over age 65 are most likely to
be hospitalized due to influenza, and healthy school-aged children and adolescents often spread influenza to
their more vulnerable family members. Influenza vaccine provides 68% protection against pediatric
hospitalization, but only half of children receive the vaccine (rates are lower for rural and Black children). Each
year in the U.S., ≥20,000 women and 15,000 men develop HPV-related cancers. Almost all cases of cervical
cancer and ~70% of oropharyngeal cancer are caused by HPV. Fortunately, if given prior to exposure, HPV
vaccine is nearly 100% effective, so the vaccine series is recommended to start at ages 9-12. Schools play a
role in making sure students receive those vaccines that are mandated by law, but also have the potential to
promote influenza and HPV vaccination. Increasing confidence in the safety and efficacy of vaccines and
building trust are crucial to enhance vaccine uptake. School-based trusted messengers, including school
nurses, school physicians and health teachers, as well as administrators, have the potential to act as trusted
messengers for vaccine information. In addition, schools communicate with parents by email and messaging
apps, where vaccine reminders can be sent. Our novel ‘Theater for Vaccine Hesitancy’ (TVH) training, based
in social determination theory, trains trusted messengers in productive conversations with vaccine hesitant
patients. It will be combined with education and resources about influenza and HPV vaccination, as well as
direct parent messaging from school, to encourage vaccination. Specifically, we will: 1) Modify existing
vaccine promotion toolkits and interactive TVH workshops to focus on trusted school messengers supporting
influenza and HPV vaccination, 2) Measure the effect of the revised educational toolkit + TVH on influenza
vaccination rates in urban and rural schools. Assess intervention feasibility, acceptability, and cost, and 3)
Measure the effect of the intervention on HPV vaccination (any dose) in schools randomized in Aim 2. Assess
intervention feasibility, acceptability, and cost. At the conclusion of the interventions, we will have a model and
revised toolkit to implement a parent focused school-based education/reminder program to increase rates of
non-mandated recommended vaccines in rural and urban schools.

Public health relevance
Rates of absenteeism and hospitalizations due to influenza remain high, as do HPV-related cancers, despite effective vaccinations being available. We will test the effect of training school nurses and teachers as well as messages to parents from school with a goal of reducing vaccine hesitancy and increasing influenza and HPV vaccination rates for children and adolescents, to ultimately reduce influenza and HPV-related morbidity and mortality.